Mapping the neuronal circuitry underlying indirect striatal to hypothalamic connectivity and its role in feeding

The Project Summary
Food consumption is fundamental to species survival and understanding the neuronal circuitry underlying
feeding behaviors is of the utmost importance. Amassing evidence supports the idea that control of caloric intake
is complex and involves calculations of hedonic value, reward and motivation. Thus, it requires interactions
between brain regions classically implemented in feeding (such as the lateral hypothalamus; LH) and the regions
modulating reward (such as the ventral striatum). While the intersection of these regions has been suggested,
the cell-type specific circuitry linking these pathways is poorly understood. The objective of this proposal is to
further elucidate the cell-type specific circuitry underlying striatal-to-lateral hypothalamic connections and
determine its role in feeding, while gaining training in new neuronal circuitry mapping techniques.
There is evidence that the striatum exerts its control over feeding behaviors by interfacing with the LH.
Previous research indicates that the ventral striatum, and specifically the nucleus accumbens shell (NAcS), and
the LH are connected via a direct pathway. However, rudimentary tracing and behavioral studies have suggested
a second, indirect pathway, with the NAcS projecting to the ventral pallidum (VP), which in turn projects to the
LH. However, despite this initial evidence, cell-type specific, neuronal circuitry in this indirect pathway remains
unknown. Using viral tracing methods, in vivo fiber photometry, fast-scan cyclic voltammetry and chemogenetic
approaches I will determine the cell-types implicated in each component of this three-part circuitry, and how they
mediate feeding behaviors. While I have growing evidence that GABAergic striatal projection neurons expressing
the dopamine D2 receptor in the NAcS preferentially innervate the VP to control feeding, I will now turn my
attention to the second part of the circuitry. I hypothesize that this population of GABAergic cells in the VP, which
receives NAcS input, in turn disinhibits LH GABA neurons to facilitate feeding.
Furthermore, in understanding the brain pathways and connectivity underlying food intake behaviors, this
project will ultimately allow us to better understand perturbations that occur in disease states such as obesity.

Public health relevance
Narrative Food consumption is rudimentary to species survival and understanding the neuronal circuitry underlying feeding behaviors is of the utmost importance. The regulation of food intake requires interactions between brain regions classically implemented in feeding (such as the lateral hypothalamus) and the regions modulating reward (such as the ventral striatum). The objective of this proposal is to further elucidate the cell-type specific circuitry underlying striatal-to-lateral hypothalamic connections and determine its role in feeding, while gaining training in new neuronal circuitry mapping techniques. Page 7 Project Narrative